Cut and paste of myosin binding protein-C in skeletal muscles

PROJECT SUMMARY
The overall goal of this project is to understand how myosin binding protein-C (MyBP-C) regulates
contraction and relaxation in skeletal muscles. 3 distinct paralogs of MyBP-C encoded by 3 separate
genes, MYBPC1, MYBPC2, and MYBPC3, are expressed in slow twitch skeletal muscle, fast twitch
muscle, and cardiac muscle, respectively. Of the three, the cardiac paralog has been most intensively
studied because mutations in MYBPC3 are the most common cause of hypertrophic cardiomyopathy
(HCM). However, like MYBPC3, it is now clear that mutations in MYBPC1 and MYBPC2 are
increasingly linked to congenital skeletal muscle diseases such as distal arthrogryposis and more
recently to a new class of familial muscle tremors. Despite this, it has been challenging to disentangle
the distinct functional roles of the 2 skeletal paralogs of MyBP-C in part because most skeletal muscles
contain a mixture of slow and fast fiber types and because MyBP-C1, expressed in slow twitch fibers,
undergoes extensive alternative splicing resulting in a family of differentially expressed proteins each
with unique functional effects. As a result, it has been nearly impossible to distinguish the functional
significance of each variant in the context of working muscles. To overcome these challenges, the PI’s
lab recently developed a novel “cut and paste” approach to selectively target and replace different
MyBP-C paralogs in muscle sarcomeres. The method, first developed for MYBPC3, relies on the use
of gene-edited mice that express a tobacco etch virus protease (TEVp) consensus site and a “SpyTag”
sequence within cardiac MyBP-C so that when detergent-permeabilized myocytes are treated with
TEVp MyBP-C is selectively cleaved. Next, MyBP-C can be replaced with any recombinant protein
(containing any desired sequence modification) as long as the recombinant protein encodes a
“SpyCatcher” sequence because SpyCatcher and SpyTag from an instantaneous covalent bond. Here,
we expanded the method by creating “SpyC1” mice that allow us to selectively study slow skeletal
MyBP-C (Aim 1) and “SnoopC2” mice to study fast skeletal MyBP-C (Aim 2). Preliminary data using
the cut and paste method has already yielded new insights into how MyBP-C dysfunction can lead to
muscle tremors and additional results from these studies will determine the functional significance of
each MyBP-C paralog and how mutations in MyBP-C cause disease.

Public health relevance
PROJECT NARRATIVE Mutations in myosin binding protein-C (MyBP-C), a muscle regulatory protein, are increasingly linked to congenital skeletal muscle diseases including those that cause clubfoot and familial tremors, but the role of MyBP-C in normal muscle function and the mechanism(s) by which mutations cause disease remain poorly understood. Here, we describe a new approach developed exclusively in the PI’s lab that will allow us for the first time to selectively modify MyBP-C in working muscles in real time. Results from this study will provide critical insights into how MyBP-C regulates muscle function and how mutations cause disease.